DISCOVERY - Repository Core

ABSTRACT (REPOSITORY CORE)
Leveraging the existing institutional, NIH-funded resources and our vast expertise in centralized, large-scale
state-of-the-art data management for clinical research, the DISCOVERY Repository Core will deliver the
infrastructure and maximize utilization and sharing of the de-identified clinical, imaging, and biospecimen data
both between network sites and, through an open-access data-sharing process in accordance to resource/data
sharing plans and in full compliance with clinical research-related regulations, with the wider scientific
community. The DISCOVERY Repository Core personnel have in-depth expertise in managing and sharing the
types of large, multi-center, multi-modal data that will be produced by this project. Among other projects, the
DISCOVERY Repository Core leadership has oversight, technical and development roles in the MarkVCID
Consortium and will leverage that infrastructure and capabilities as a basis for the DISCOVERY Repository. The
DISCOVERY Repository system will provide a web portal that serves as the main entry point into the project’s
resources. The portal will comprise a set of capabilities to provide project information, data management, data
integrity and quality, access requests, querying, and download. The Repository will fully integrate the imaging,
clinical assessment instrument, and biospecimen metadata into its query capability. The DISCOVERY
Repository will leverage the MarkVCID infrastructure and the infrastructure and experience of the Biospecimens
repository developed through the Alzheimer’s Clinical Trial Consortium (ACTC) U19 to build the necessary
capabilities to handle the anticipated increase in data flow that will require different back-end processes and
handle the new data types in the DISCOVERY set of biomarkers. The Repository Core will: 1) To create an
integrated data management infrastructure that follows the best practices for data management established by
MarkVCID consortium and NIH guidance documents; 2) develop a repository infrastructure that will allow data
to be “findable” and “accessible”; 3) create a metadata infrastructure that will allow data to be “interoperable” and
“reusable”. The DISCOVERY repository will leverage work by other NIH repositories and ontology-development
groups to create metadata that maximizes interoperability, using well-established terms and common data
elements wherever possible, so that data consumers are able to understand and successfully reuse data
generated by others. Successful sharing and reuse are also predicated on the assurance of data quality and
integrity. We will deploy an extensive suite of tools to ensure that data stored in the Repository is consistent and
of the highest quality. The DISCOVERY Repository will follow the FAIR principles and we expect that adherence
to those principles will maximize utilization of this unique data set and develop an “open-access” platform as an
enduring resource for the future scientific breakthroughs in stroke and VCID.